Administrative Core

PROJECT SUMMARY ADMINISTRATIVE CORE
The Administrative Core (AC) of NeuroTech Harbor (NTH) will direct, coordinate, and lead the Outreach,
Evaluation, Innovator, and Resource Cores to efficiently achieve the following goals: (i) Be a national leader in
the support and development of real-world solutions to neurological problems and ensure that it does so in a
way that reflects our Equitech values of inclusivity and equity in both the people involved and the projects it
supports. (ii) Act as an excellent steward of federal funds to achieve maximum return for NIH and society at
large. The AC will consist of the Governing Board, Steering Committee, and Advisory Board. The AC will serve
as a central leadership team that will continually assess, refine, and improve NTH processes to achieve better
results. NTH's AC will accomplish the following aims: (Aim 1) To ensure excellence in Governance and
Management at NTH. (Aim 2) To coordinate all NTH Core interactions with the Steering Committee (SC),
Advisory Board (AB), and Consultant Network. (Aim 3) To prepare NTH-selected meritorious innovation projects
for NIH funding consideration and ensure success of funded projects. (Aim 4) To actively communicate best
practices and collaborate across the BluePrint Hub consortium.
We have assembled a Governing Board led by NTH PIs serving as Directors of each Core. As the founding
institutional partners of NTH, the Governing Board will be led jointly by Co-Chairmen Dean Schlesinger from
JHU and Provost Dr. Wutoh from Howard. The Governing Board will ensure that the Equitech approach of NTH
is front and center to all decisions and actions in each individual Core's plans. The AC will also act as the final
arbiter of conflicts and take action to maximize likelihood of success for NTH, Cores, and subprojects. While
Core Directors will separately manage the budgets, personnel, processes, and goals for each Core, the AC will
act as a central coordinator for all Cores to receive regular input and oversight from the SC and AB. The AC will
consider appropriate SC members for (1) Outreach Core needs assessments and NTH solicitations, and (2)
reviews with the Evaluation Core to ensure the highest impact innovation projects are selected.
The AC team will convene an annual Governing Board meeting with key AB members to continuously identify
areas of improvement in quality, efficiency, outcomes, and responsiveness in response to the changing
landscape of medical needs, technological breakthroughs, and scientific advancements in the neurology space.
The AC will coordinate access to an external Consultant Network of experts who span a broad range of expertise
(early-stage technology, clinical translation, or business development) to assemble the Dream Tech Team for
each innovator project. In the Innovator Core will support innovators with the guidance and resources necessary
for building solutions for optimal real-world impact. The AC will be responsible for coordinating interactions with
NIH BluePrint (BP) program staff on strategic planning. In addition, the AC will work with each Core's staff to
collect, analyze, and disseminate our outcomes and best practices to the BP network.